Finding combinatorial drug repositioning therapy for Alzheimer's disease and related dementias

Summary
Artificial intelligence and machine learning (ML) models are becoming increasingly popular in
clinical applications. If we allow these “autonomous” ML models to make recommendations for
clinical decisions, it is important to ensure that they do introduce algorithmic unfairness (e.g.,
differences in the burden of disease or opportunities of treatment for different populations). We
propose novel technological solutions to mitigate algorithmic unfairness. We will address two
major types of data biases (subgroup and representation) to reduce their negative impact on ML
models. Based on contextual information and novel causal inference techniques, we will identify
potential outliers and task-irrelevant confounders and address them with customized mitigation
strategies (e.g., down-sampling and factor reduction) to avoid learning erroneous information
that might lead to health disparities. In addition, we will propose FairAUC (a new optimization
mechanism) to maximize prediction accuracy while considering fairness by design. As opposed
to post-hoc fairness rectification approaches, our method will automatically consider both
objectives in the training phase to strike the optimal balance between accuracy and fairness.

Public health relevance
Project Narrative We propose to develop novel methodologies to address potential algorithmic unfairness and ameliorate health disparity in machine learning models. This project will address data bias by transforming and disentangling data (Aim 1) and ii) addressing model bias algorithmically by fair optimization for various parity metrics and equal opportunity. (Aim 2).